Ruth L. Kirschstein NRSA Short-Term Institutional Research Training Grant (T35)

Project Summary
This is a renewal proposal requesting an additional five years of T35 funding to support a three-month summer
training program at the National Center for Rehabilitative Auditory Research (NCRAR) for students enrolled in a
Doctor of Audiology (Au.D.) clinical degree program. We request funding to cover four students annually for the
duration of the grant. Dawn Konrad-Martin, Ph.D. will be the Program Director. She will be assisted by the
NCRAR Education and Outreach Manager and an Advisory Committee. The long-term objective of our program
is to increase the number of individuals with a clinical Au.D. who go on to pursue a Ph.D. and a career in auditory
research. The NCRAR is a VA-funded research center consisting of 16 Ph.D. investigators, all of whom will serve
as T-35 faculty. NCRAR is unique among auditory research facilities because of its focus on diagnosis,
rehabilitation and prevention of auditory and balance disorders through translational and applied human studies,
many of which use clinical methodologies to obtain data. It thus has particular appeal and application to the
clinical Au.D. students for whom the program is designed.
During the summer, each student works with their mentor to design and conduct a research project, while also
working in their mentor's laboratory, attending courses held by NCRAR faculty and guests, participating in
NCRAR journal groups, meetings and seminars, holding discussions with each NCRAR Investigator, and visiting
other local research facilities. Finally, students are required to present their mentored research project to
members of the NCRAR, and at the American Auditory Society annual meeting. They are also encouraged to
work with their mentor to publish the findings of this project.
All students enrolled in an accredited Au.D. program are eligible to participate. The program is publicized via
email and phone calls to Au.D. Department Chairs and student advisors, on the NCRAR website, and at
audiology conferences. To apply, students must send a statement of interest describing what they hope to gain
from the traineeship, a curriculum vitae, at least two letters of recommendation and an applicant evaluation form
completed by their Au.D. program advisor. Applications are evaluated by the NCRAR faculty using their personal
statement, letters of recommendation, the applicant evaluation form and undergraduate GPA as metrics.
Since 2007, 56 trainees have matriculated through NCRAR's T35 program. Six are research audiologists, 3 are
currently enrolled in Ph.D. programs, 1 is a postdoctoral research fellow, and 7 are university professors or
instructors. These data, combined with highly positive evaluations from participating students and the NCRAR
faculty demonstrate that our program successfully accomplishes the goals of the NIH T35 training program `to
encourage Au.D. students to develop research career trajectories through pursuing sustained programs of
research training and career development in order to advance the state of-the art in hearing health care services'.

Public health relevance
Project Narrative This is a renewal proposal requesting an additional five years of funding to support a three-month T35 summer training program at the Department of Veterans Affairs, National Center for Rehabilitative Auditory Research (NCRAR) for students enrolled in a Doctor of Audiology (Au.D.) clinical degree program. The goal of the program is to encourage an interest in hearing and balance research and research careers through intensive short-term immersion in an auditory and vestibular research environment combined with a mentored research project.